Contract Orientation and Kickoff Meeting

This contract supports the PREVENT Cancer Preclinical Drug Development Program, which provides a structured
approach to drug and vaccine development, from discovery to the clinic. This contract is part of a multiple-award Indefinite Delivery Indefinite Quantity (IDIQ) pool to procure services related to Toxicology and Pharmacology Testing, which is also referred to as the "Toxicology Pool."